Influence of Dietary Lipids on Gestational Outcomes of Ozone Exposure

Pregnancy induces a wide range of physiological changes in the body, and can serve as a particularly
vulnerable period to both the developing fetus and the mother. Remodeling of the uterine circulation during the
implantation period of pregnancy results in hemodynamic and cardiovascular alterations as the nutrient needs
of the fetus expand. Improper vascular reorganization during placentation can result in placental insufficiency
and subsequent pathological responses to the maternal cardiac system. Gestational hypertension and
preeclampsia are prevalent vascular disorders that significantly increase the risk for both premature birth as
well as postnatal maternal cardiac sequelae. Air pollution is a known inducer of vascular damage and cardiac
disease, and resent research has shown that gestational exposure to air pollution is correlated with increased
incidence of preeclampsia. The current study seeks to examine how ozone as a major constituent of air
pollution interacts with the epithelial lining fluid of the maternal lung utilizing a mouse model, and how this
environmental exposure may cause systemic effects that are detrimental to normal fetoplacental growth and
development. Furthermore, this study intends to determine the effect of dietary supplementation of fatty acids
on modifying the lipid composition of the epithelial lining fluid, and subsequent lung injury following ozone
exposure. Dietary fatty acids are important mediators of vascular integrity. Supplementation with oils high in
omega three fatty acids has been studied in the context of cardiovascular integrity, as well as for possible
protective effects against neurodegenerative disorders. Specifically, omega three fatty acids have been shown
to produce anti-inflammatory effects against respiratory irritants. This study will use a C57BL/6 model to
examine how ozone toxicity at early stages of gestation lead to systemic, pathological changes in maternal
vascular remodeling. The overall hypothesis of this proposal is that increased dietary uptake of
polyunsaturated fatty acids will ameliorate acute ozone induced maternal lung injury, providing a protective
effect against systemic vascular effects and placental insufficiency caused by improper angiogenic remodeling.
We will address the acute effects through lipidomic profiling of maternal lungs after ozone exposure, along with
analysis of cellular and circulating mediators of inflammation. The long term gestational effects will be
quantified through echocardiographic analysis and in vivo imaging of vascular leakage to assess the extent of
damage caused by ozone exposure during implantation. Upon completion of this study, this work will contribute
to the conceptual advancement of our understanding of how ozone induced lung injury can be modified by diet,
and if dietary supplementation may be a considered as a protective measure for women at high risk for
exposure to air pollution during pregnancy.

Public health relevance
Pregnancy involves intensive vascular remodeling of the uterine artery to accommodate increasing oxygen demand by the fetus, and so is vulnerable to damage from cardiovascular damaging toxicants such as exposure to ozone in air pollution. The proposed study seeks to examine how dietary lipids influence ozone induced maternal lung injury and subsequent systemic vascular damage. Completion of this work will contribute to our understanding of potential protective effects of dietary lipids on the amelioration of systemic consequences of inhaled reactive toxicants.